New York Regional Center for Diabetes Translation Research

The New York Center for Translational Research (NY-CDTR) presents an evolution of our National Resource Core, newly titled “Psychosocial Research on Intervention Science and Mechanisms of Disease in Diabetes” (PRISM-D). The PRISM-D Core aims to catalyze high-impact translational research addressing the complex interplay of psychological, social, and contextual factors in diabetes risks, management, and outcomes. This evolution aligns with research demonstrating that negative (e.g., depression, diabetes distress) and positive (e.g. positive affect, social support) psychosocial factors relate to diabetes risk and outcomes through interrelated behavioral (e.g., medication adherence, dietary patterns) and biological mechanism (e.g., inflammation, insulin resistance); that psychosocial challenges are prevalent among individuals with diabetes and negatively impact diabetes outcomes and healthcare costs; and, that interventions addressing psychosocial needs can support effective self-management and improve patient reported and clinical outcomes among people with diabetes. The evolved emphasis is also consistent with current diabetes care guidelines that highlight the importance of Integrating psychosocial support throughout the diabetes care continuum to improve long-term outcomes. These changes in scientific knowledge and clinical practice have fostered increased requests from National Resource Core users seeking resources in the psychosocial sphere. To meet these needs, the PRISM-D’s national investigative team will leverage our multi-disciplinary expertise and experience in areas including psychosocial and behavior change theory and measurement, with emphasis on innovative methods to assess psychosocial experiences, glycemic regulation, and intervention responses in real-time; developing and testing evidence-based diabetes prevention and intervention strategies that integrate psychosocial dimensions of health; and, employing community engaged research strategies and partnerships to create sustainable interventions that reach the populations at highest risk for diabetes and its complications. Building on past accomplishments and successful strategies of our prior National Resource Core, the PRISM- D core will offer consultations and services that support the following specific aims: 1) Develop a National Research Network of investigators conducting rigorous research to advance translational science on the psychosocial dimensions of diabetes. 2) Provide targeted consultations and methodological support to integrate psychosocial factors into studies of diabetes risk, prevention, management, and intervention. 3) Support and accelerate research addressing psychosocial dimensions of diabetes by leveraging existing datasets and infrastructure. Through these efforts, the evolved PRISM-D National Resource Core will significantly extend the national reach and impact of the NY-CDTR in promoting translational research that addresses diabetes risk, management, outcomes, and intervention through a biopsychosocial lens.

Public health relevance
The New York Regional Center for Diabetes Translation Research (NY-CDTR) is seeking is first competitive renewal in order to continue to maximize the assets devoted to diabetes translation research in the high-need New York area. With this application, we expand our services and enhance our focus on social aspects of health. The NY-CDTR greatly expands the resources to support type 2 translational research on diabetes and obesity and foster further collaborative efforts to drive cutting-edge translational research throughout the New York region, with the Albert Einstein College of Medicine serving as a central collaborating hub for these efforts. Our National Resource Core enhances our impact on the national level. The intrinsic strength of our multidisciplinary research base of patient- and community-centered activities provide an integrated platform upon which the NY-CDTR has developed and will continue to expand strong linkages, leveraging our several NIH-funded Centers and institutional resources. The goals of the NY- CDTR are to continue to improve and expand delivery of existing services, develop innovative new services and increase the breadth of our translational research base to focus on T3-T4 translational research projects targeting diabetes across populations in collaboration with multi-sector and multi-stakeholder partners. Our growth in membership, productivity in outcomes, and our research base over our first funding period positioned us extremely well for continued national impact. Guided by our Center theme that focuses on a biopsychosocial approach, we focus on these Specific Aims: 1) To foster the growth and development of an existing outstanding scientific base devoted to type 2 translational research related to the prevention and control of diabetes and its complications by supporting and administering four translational research cores, including a National Resource Core: a) Behavioral Science and Technology Core, b) Life Course Methodology Core, c) Population Health and Health Systems Core, d) Psychosocial Research on Intervention Science and Mechanisms of Disease in Diabetes (PRISM-D): A National Resource Core. 2) To promote a Pilot & Feasibility Study Program that supports initiation of diabetes translation research programs and enhances the careers of new investigators. 3) To support and organize an Enrichment Program by making accessible outstanding, live and virtual, interactive, external and internal seminars, podcasts, faculty/trainee conferences. 4) To provide an Administrative Core as the principal means of planning, implementing and evaluating the programs in research, training, resources and enrichment activities. 5) To expand and integrate the scientific efforts of the NY-CDTR with our innovative Psychosocial Research on Intervention Science and Mechanisms of Disease in Diabetes (PRISM-D) national resource core that engages investigators leading NIH-funded diabetes translation research. Modified Specific Aims Section Located in the Bronx, New York, among the poorest urban counties in the U.S., and based at the Albert Einstein College of Medicine and Montefiore Health Systems, the NY-CDTR serves as a regional nexus for diabetes-related translation research, education, and training. Our location and the health challenges experienced by the people we serve have influenced our track record of diabetes translation research focused on various populations and groups across the life span. Building on strong multisector academic, health system, community, and health department collaborations developed over four decades of NIDDK Center support at Einstein for diabetes prevention and control research, we successfully bridge collaborations across institutions throughout the New York metropolitan area. These collaborations have positioned the NY-CDTR as a significant resource to guide diabetes research during the COVID-19 pandemic, where Montefiore was an early epicenter of the outbreak and leader in COVID-19 related collaborative translational research. In addition, the reach of the NY-CDTR is truly national, through a National Resource Core that promotes diabetes translation research focused on psychosocial research across the population. Our Core services, Programs, and Resources are guided by our Center themes that focus on a biopsychosocial approach to develop and support diabetes translational research that can impact population health through a robust research base and a national network of members. The NY-CDTR supports an innovative and coordinated set of administrative and Core services, enrichment programming, as well as early-stage investigator (ESI) career development activities, and pilot and feasibility study funding. We provide services through three seamlessly across academic institutions, healthcare systems, community organizations, and health departments without the typical administrative red tape or additional fee structures that hamper these types of efforts. Our goals are to improve existing services, develop new services, increase the breadth and collaborative nature of diabetes translation research, further enhance ESI career development activities, and accelerate local and national impact on diabetes through these Specific Aims: AIM 1. To ensure a scientific environment that supports and accelerates growth and development for an outstanding research base devoted to diabetes translational research by administering four vibrant research Cores, including a National Resource Core: a) Behavioral Science and Technology Core (formerly, Translational Intervention Methodology Core) b) Life Course Methodology Core c) Population Health and Health Systems Core d) Psychosocial Research on Intervention Science and Mechanisms of Disease in Diabetes (PRISM-D): A National Resource Core AIM 2. To implement and provide oversight and mentoring for an effective Pilot & Feasibility Study Program that supports initiation of diabetes translation research and enhances the careers of early-stage investigators. AIM 3. To oversee and organize the Enrichment Program by offering and evaluating accessible outstanding, interactive seminars, works-in-progress presentations, and faculty/trainee workshops and conferences. AIM 4. To provide an Administrative Core as the principal means of planning, implementing and evaluating the programs in research, training, resources, pilot and feasibility awards and Enrichment activities. AIM 5. To raise awareness of Core services and collaborative opportunities and to expand and integrate our scientific and Enrichment efforts throughout our network, and through partnerships with various organizations and other NIDDK-supported Centers, leveraging a rich array of institutional resources to enhance our impact. Modified Public Health Relevance Section The overall goal of the Population Health and Health Systems (PHHS) Core is to promote high quality diabetes-related translational research within the community and health system settings. The PHHS Core will continue to support obesity and diabetes investigators, health systems, and public health and community organizations to develop and disseminate translational research programs that improve patient and population health. Through effective collaboration with expert, multidisciplinary faculty, the PHHS Core will seek to improve uptake of research findings into policy and practice to more rapidly disseminate effective models across community and health care settings, thereby increasing potential for sustainable improvements in diabetes-related outcomes. PHHS Core services include: facilitating access to multi-level data that can inform diabetes-related health, providing expertise in innovative analytic methods and study designs for complex systems, and facilitating access to community and health system partnerships that can inform implementation and sustainability of best practices. The specific aims of the PHHS Core are: 1) provide community engagement expertise leveraging public health, health systems, and community-based partnerships to accelerate innovative diabetes translation research across the region; 2) provide consultation and technical support for health systems research that promotes efforts to develop, sustainably implement, rigorously evaluate, and disseminate effective diabetes prevention and management interventions; and 3) provide consultation and guidance to investigators in analytic methodologies, using big data to inform interventions that address factors that influence health, systems, and policy. Through our partnerships, we will promote collaboration and provide technical support to translational investigators, health systems, and public health colleagues to further their efforts to inform health-related policy, develop, implement, rigorously evaluate, and disseminate effective diabetes prevention and management interventions in communities at risk and within health systems. In this new funding cycle, we plan to attract more investigators working with clinical and community populations with an interest in addressing the population- community- and health system-factors that influence diabetes health outcomes. We will also engage community partners as part of a team science approach to disseminating best practices in obesity and diabetes prevention and control. Modified Specific Aims Section The overall goal of the Population Health and Health Systems (PHHS) Core is to promote high quality diabetes-related translational research within the community and health system settings. The 2020 NIH-sponsored Pathways to Prevention Workshop identified three cross cutting themes crucial to addressing access to health care and the use of clinical services that prevent chronic diseases including diabetes. These themes are: 1) Community engagement and systems approaches; 2) Integration of services and new delivery models, and 3) Need for innovative methods. Over the first funding period of the New York Regional Center for Diabetes Translation Research (NY-CDTR), the PHHS Core provided investigators access to expertise in learning health systems, data informatics, and data infrastructure, as well as novel designs for community engaged research. The P2P report highlights the need for attention to the social factors that influence health as central to these recommendations to improve access to preventive services. For this renewal, the PHHS Core aims to build on our past success by providing access to expertise in multisector partnerships across the NY-CDTR network. The PHHS Core will evolve to support a fuller range of T3-T4 translation spanning outside of the clinical setting by offering additional resources in health-related policy, social aspects of health, and community engaged diabetes translation research. New faculty recruited to the PHHS Core increase capacity to provide consultation in quasi-experimental research designs, and systems and simulation modeling approaches. We will continue to support diabetes and obesity investigators as they develop, evaluate, and disseminate translational research programs that improve individual and population health. Through effective collaboration with expert, multidisciplinary faculty, the PHHS Core will seek to improve uptake of research findings into policy and practice to more rapidly disseminate effective improvements in health outcomes. The specific aims for the PHHS are: Aim 1: To provide community engagement expertise leveraging public health, health systems, and community-based partnerships to accelerate innovative diabetes translation research across the region. Services include consultation in methods to facilitate high quality studies targeting populations at risk, recognizing that natural experiments, observational studies, health system initiatives, and community-level interventions may require quasi-experimental, mixed-methods, and other robust evaluation methodologies appropriate in real world settings. An innovative new service provides consultations from Health People, a community health organization delivering community-supported, peer-to-peer, evidence-based diabetes prevention and control programs. Aim 2: To provide consultation and technical support for health systems research that promotes efforts to develop, sustainably implement, rigorously evaluate, and disseminate effective diabetes prevention and management interventions. Services include access to expertise in practice-based research, health services research, evaluation methods, data informatics, and dissemination and implementation of interventions. Core faculty will work to make these data-related resources more accessible and more actionable, helping investigators effectively use health information technology resources to answer important questions related to diabetes and obesity prevention and control. Aim 3: To provide consultation and guidance to investigators in analytic methodologies, using big data to inform interventions that address social aspects of health, systems, and policy. Services include consultation with faculty with expertise in social aspects of health and social needs research. We facilitate access to large local and regional databases to support translational diabetes-related research. The PHHS Core will leverage Einstein-Montefiore data systems and collaborations with the New York City Department of Health and Mental Hygiene (NYC DOHMH), Bronx Regional Health Information Organization (RHIO), and the INSIGHT Clinical Research Network, which collects and harmonizes clinical records across multiple institutions within NYC. New partnerships in this renewal include New York University’s Comprehensive Obesity Program and their data integration efforts across basic science, clinical medicine, and population health (DataBridge), which will be leveraged to develop collaborative linkages to CDTR members. Modified Public Health Relevance Section The overall goal of the Life Course Methodology Core (LCMC) of the New York Regional Center for Diabetes Translation Research is to support high quality type 2 translational research in diabetes prevention and control across the life span. The life course perspective focuses on the biopsychosocial and behavioral processes that individuals experience during particular periods in their life and examines the interplay between these exposures in shaping disease risk. Currently, there is strong evidence from observational studies that the processes that lead to the development of diabetes start early in life and continue throughout the lifespan. This life course approach also can enhance the translation of efficacious interventions by ensuring that intervention strategies are appropriate for the age group targeted and address associated individual or environmental factors. Following this line of thought, we propose a two-pronged approach that identifies the most relevant modifiable contributors to disease and the most appropriate interventions taking into account the life stage targeted. The LCMC will leverage existing multidisciplinary expertise and infrastructure to facilitate application of a life course perspective to new translational diabetes research. Einstein investigators and their collaborators have accumulated decades of expertise in diabetes research across the life span and are well positioned to contribute to the acceleration of translational research. The LCMC will provide conceptual and instrumental support regarding the design, and implementation of new translational diabetes research across the life span with the goal of decreasing the burden of diabetes and alleviating poor diabetes health outcomes. The LCMC specific aims are: 1) To build capacity in using the life course approach to the design of new translational diabetes research; 2) To facilitate the implementation of new translational diabetes research; 3) To provide consultation and mentorship on biological factors underlying diabetes outcomes across the lifespan. Modified Specific Aims Section The Life Course Methodology Core (LCMC) fosters the integration of a life course perspective in diabetes translation research. The LCMC core provides skills and resources for understanding the unique influences operating in diabetes risk at each lifespan period, which is crucial for diabetes management and prevention. Pathways specific to a lifespan period represent opportunities to modify adverse trajectories and interrupt the path to diabetes and its sequela. The LCMC aims to accelerate the integration of new knowledge into improved treatment and prevention programs for populations adversely affected by diabetes. The life course approach to understanding the root causes of differences in diabetes risk across individuals and communities has been underutilized. The factors that influence risk start early in life and often persist across the lifespan. There may be critical periods in the life course when factors have the greatest effects on future health. On the other hand, early and cumulative adversities can be modified later in life. Furthermore, the study of factors that promote resilience offers an opportunity for prevention along the lifespan to redirect trajectories to healthier patterns. Specific aims are as follows: AIM 1: To build capacity in using the life course approach to the design of new translational diabetes research. The LCMC will assist investigators in implementing the NIH policy of inclusion of populations across the lifespan and the translation of results to populations across the lifespan. Consultation services in this core will include conceptual models in life course research; novel statistical approaches; and building infrastructure for life course research. AIM 2: To facilitate the implementation of new translational diabetes research. Services provided in this core will include consultations to guide selection of measures and instruments that are age-relevant for critical periods; consultation on theory-driven translational interventions for children, middle age adults and older adults; assessments using mobile technology; and, support investigation of potential resilience factors. AIM 3: To provide consultation and mentorship on biological factors underlying diabetes risk across the lifespan. Leveraging existing multidisciplinary expertise and resources at Einstein, Modified Public Health Relevance Section The overall goal of the Life Course Methodology Core (LCMC) of the New York Regional Center for Diabetes Translation Research is to support high quality type 2 translational research in diabetes prevention and control across the life span. The life course perspective focuses on the biopsychosocial and behavioral processes that individuals experience during particular periods in their life and examines the interplay between these exposures in shaping disease risk. Currently, there is strong evidence from observational studies that the processes that lead to the development of diabetes start early in life and continue throughout the lifespan. This life course approach also can enhance the translation of efficacious interventions by ensuring that intervention strategies are appropriate for the age group targeted and address associated individual or environmental factors. Following this line of thought, we propose a two-pronged approach that identifies the most relevant modifiable contributors to disease and the most appropriate interventions taking into account the life stage targeted. The LCMC will leverage existing multidisciplinary expertise and infrastructure to facilitate application of a life course perspective to new translational diabetes research. Einstein investigators and their collaborators have accumulated decades of expertise in diabetes research across the life span and are well positioned to contribute to the acceleration of translational research. The LCMC will provide conceptual and instrumental support regarding the design, and implementation of new translational diabetes research across the life span with the goal of decreasing the burden of diabetes and alleviating poor diabetes health outcomes. The LCMC specific aims are: 1) To build capacity in using the life course approach to the design of new translational diabetes research; 2) To facilitate the implementation of new translational diabetes research; 3) To provide consultation and mentorship on biological factors underlying diabetes outcomes across the lifespan. Modified Specific Aims Section The Life Course Methodology Core (LCMC) fosters the integration of a life course perspective in diabetes translation research. The LCMC core provides skills and resources for understanding the unique influences operating in diabetes risk at each lifespan period, which is crucial for diabetes management and prevention. Pathways specific to a lifespan period represent opportunities to modify adverse trajectories and interrupt the path to diabetes and its sequela. The LCMC aims to accelerate the integration of new knowledge into improved treatment and prevention programs for populations adversely affected by diabetes. The life course approach to understanding the root causes of differences in diabetes risk across individuals and communities has been underutilized. The factors that influence risk start early in life and often persist across the lifespan. There may be critical periods in the life course when factors have the greatest effects on future health. On the other hand, early and cumulative adversities can be modified later in life. Furthermore, the study of factors that promote resilience offers an opportunity for prevention along the lifespan to redirect trajectories to healthier patterns. Specific aims are as follows: AIM 1: To build capacity in using the life course approach to the design of new translational diabetes research. The LCMC will assist investigators in implementing the NIH policy of inclusion of populations across the lifespan and the translation of results to populations across the lifespan. Consultation services in this core will include conceptual models in life course research; novel statistical approaches; and building infrastructure for life course research. AIM 2: To facilitate the implementation of new translational diabetes research. Services provided in this core will include consultations to guide selection of measures and instruments that are age-relevant for critical periods; consultation on theory-driven translational interventions for children, middle age adults and older adults; assessments using mobile technology; and, support investigation of potential resilience factors. AIM 3: To provide consultation and mentorship on biological factors underlying diabetes risk across the lifespan. Leveraging existing multidisciplinary expertise and resources at Einstein, Modified Public Health Relevance Section The Administrative (ADM) Core of the New York Regional Center for Diabetes Translation Research (NY- CDTR) provides the fundamental infrastructure necessary to strengthen such research at the Albert Einstein College of Medicine with Montefiore Health Systems, and other partnering institutions of our Core faculty and members to stimulate the next generation of diabetes translation research through the following aims: 1) To provide dynamic and responsive leadership. The ADM will afford consistent scientific leadership to articulate and implement a clear vision for the translational research direction of the Center. The Program Director, Jeffrey Gonzalez, PhD, will provide strong and responsive leadership to accelerate translational research on diabetes and obesity that contributes to public health improvements in diabetes outcomes. 2) To provide robust infrastructure for the maintenance of four cutting edge Translational Research Cores. We have developed and refined four Translational Research Cores furnishing the infrastructural bedrock of the NY-CDTR: Behavioral Science and Technology Core; Life Course Methodology Core; Population Health and Health Systems Core; and the Psychosocial Research on Intervention Science and Mechanisms of Disease in Diabetes” (PRISM-D): A National Resource Core. 3) To administer vibrant Center Programs, including an Enrichment Program and a Pilot and Feasibility (P&F) Grant Program. The ADM will leverage the many resources of our collaborating academic institutions, funded Centers and CTSAs, so that the Enrichment Program activities are accessible for members as well as potential new members; there is also a heightened awareness of the wealth of educational programs for diabetes translational investigators focused on research to improve health outcomes across communities. The ADM will also provide infrastructure and support for the robust, mentored P&F Program to fund promising research proposals from early-stage investigator members. Maintenance of a useful and up-to- date NY-CDTR website will make these resources accessible to our members and non-members across the country. We will also stimulate and promote use of supplemental funding opportunities throughout our national network. 4) To objectively evaluate progress, facilitate efficiency, and ensure ethical conduct of research, and quality control, with guidance from multi-stakeholder and community-based advisors. The ADM institutes a system of reportage and evaluation to ensure that services meet expectations; initiatives continue to be effective; progress is reported in a timely and comprehensive manner; and established objectives continue to be met. The ADM will work with an Internal Advisory Committee and External Scientific Advisory Committee to ensure the cost efficient and high impact performance of all Center activities to guide the evolution of the NY- CDTR toward the next generation of diabetes translation research that is responsive to community Modified Specific Aims Section The overarching goal of the Administrative Core for the New York Regional Center for Diabetes Translation Research (NY Regional CTDR) is to build on considerable accomplishments of our initial funding period, as well as lessons learned that have resulted in carefully planned changes to improve efficiency and performance. The specific aims of the Administrative Core (ADM) are to provide: 1) strong leadership and direction to catalyze creative translational diabetes-related research aimed at reducing diabetes risk and improving health outcomes, 2) study design, biostatistical and program evaluation consultation services that cut across our Translational Research Cores; and 3) administrative support to coordinate, plan, implement, track and evaluate Center activities to facilitate diabetes translation research. The Center’s considerable growth in membership, collaborative activity, and research base over the initial funding period have been major indicators of our early success. This growth has also emphasized the need for strong administrative oversight and support for the Center’s varied activities. The ADM oversees a continual, reflective, and member-guided process of evaluation and revision of Core services to ensure responsiveness to changing member needs and research opportunities. The ADM also provides linkages to and leveraging of a rich set of institutional resources, including other NIH/NIDDK-funded Centers. Considerable growth in the scope and complexity of our Enrichment and Pilot and Feasibility Programs, increased requests for Core services, and increased interest in networking and communicating across our membership has informed adjustments in procedures over our initial funding period. These changes are optimized for the current funding period, which focuses on maximizing our impact on diabetes health outcomes and makes investments in innovative services and resources. The ADM mission focuses on efficiency, expertise, innovation and productivity, which will be realized through the following Specific Aims: Aim 1: To provide dynamic and responsive leadership. The ADM will afford consistent scientific leadership to articulate and implement a clear vision for the translational research direction of the Center. The Director, Jeffrey Gonzalez, PhD, will provide strong and responsive leadership to accelerate translational research on diabetes that contributes to improved population health outcomes. Aim 2: To provide robust infrastructure for the maintenance of four cutting edge Translational Research Cores. We have developed and refined four Translational Research Cores furnishing the infrastructural bedrock of the NY-CDTR: Behavioral Science and Technology Core; Life Course Methodology Core; Population Health and Health Systems Core; and the Psychosocial Research on Intervention Science and Mechanisms of Disease in Diabetes” (PRISM-D), a National Resource Core. Aim 3: To administer vibrant Center Programs, including an Enrichment Program and a Pilot and Feasibility (P&F) Grant Program. The ADM will leverage the many resources of our collaborating academic institutions, funded Centers and CTSAs, so that the Enrichment Program activities are accessible for members as well as potential new members; there is a heightened awareness of the wealth of educational programs for diabetes translational investigators. The ADM will also provide infrastructure and support for our robust, mentored P&F Program to fund promising research proposals from early-stage investigators. Maintenance of a useful and up-to-date NY- CDTR website will make these programs and other Center resources accessible to our members and non-members across the country. Aim 4: To objectively evaluate progress, facilitate efficiency, and ensure ethical conduct of research, and quality control, with guidance from multi-stakeholder and community-based advisors. The ADM institutes a system of reportage and evaluation to ensure that services meet expectations; initiatives continue to be effective; progress is reported in a timely and comprehensive manner; and established objectives continue to be met. The ADM will provide flexible, vigilant and timely oversight, so as to respond effectively to the latest advances in diabetes translation research and to the changing needs of our members. The ADM will work with the Institutional Administration and leverage institutional and philanthropic resources to guide the evolution of the NY-CDTR toward the next generation of diabetes translation research that is responsive to community needs and priorities, funding opportunities, and developments in technology. Modified Public Health Relevance Section The Enrichment Program of the New York Regional Center for Diabetes Translation Research (NY-CDTR) will serve as command central for coordination of enrichment activities that will include ‘Works in Progress’ seminars and research mentoring, special lectures, seminar programs, workshops, and live and virtual education in type 2 to 4 (T2 to T4) translation research methods. We take very seriously our leadership role in translation research in diabetes and see enrichment as a major venue to bring talented diabetes and related research investigators together within the institutions, across institutions in the surrounding region, and across the nation through our National Resource Core. In alignment with the health goals of the NY-CDTR, the Enrichment Program provides enrichment activities that highlight the work and expertise of the varied and talented diabetes and obesity-related research investigators in our member network. The specific aims of the program are: 1) to strengthen a novel mentoring program in which all Pilot & Feasibility awardees receive faculty support and guidance during conduct of their studies, and participate in “Works in Progress” seminars; 2) to facilitate access to various education and training enrichment activities (live and online) covering T2-T4 translational research topics in diabetes prevention and control and related metabolic disorder...